Neuro-PRECISE Center: Research Project

Modified Project Summary/Abstract Section

RESEARCH PROJECT – PROJECT SUMMARY / ABSTRACT Even though neural circuits are the foundation of neural-based function, research activity in neurorehabilitation into how to precisely modulate neural circuits for optimal therapeutic outcomes is undeveloped. Currently, there are substantial limitations in the ability of rehabilitation researchers to characterize dysfunctional neural circuits, precisely target and modulate those circuits, and pair with rehabilitation to restore function to those with physical, cognitive, and psychosocial disabilities. Thus, there is great need to advance precision neural circuit-based rehabilitation (PN) through an integrated research and development (R&D) program to champion the development of essential tools and methodologies to address specific functional deficits at the neural circuit level directly. Our aim to facilitate PN scientific discovery is to: Perform team science to develop knowledge and diagnostic tools and methods to precisely characterize, modulate, and rehabilitate neural circuits underlying function and recovery. The primary engine of an impactful Neuro-PRECISE R&D program is the Research Project. This team science research program consists of multiple subprojects (12-15) over five years and acts as our primary steering wheel to guide the development of R&D products (e.g., knowledge, tools, methods, and data) to overcome key hurdles necessary to grow PN research. Subprojects will identify participants based on patient-reported and observed dysfunction rather than a single neurological condition. After surveying our research portfolio and key needs for the field, we chose three subprojects. Subproject #1 will adapt a closed-loop rTMS-EEG system for use in PN to permit the time-locked application of rTMS pulses to the phase of the intrinsic neural oscillation. Subproject #2 will evaluate the feasibility of using personalized focused ultrasound (FUS) to modulate a deep node in the motor control network and to test its effects on motor control. Subproject #3 will evaluate the feasibility of remotely monitored, in-home delivery of combined cognitive training and taVNS to optimally address shared neural circuit dysfunction underlying multifaceted cognitive and psychosocial (e.g., mood, fatigue) dysfunction that negatively impacts self-management ability, rehabilitation outcomes, daily function, and quality-of-life for those with disabilities. Our team at MUSC has an exceptional combination of: leadership experience; expertise in characterizing, modulating and rehabilitating neural circuits; and world-class resources that can be leveraged to the benefit of the national PN research community. In summary, have assembled the necessary ingredients to advance the field of PN research through a programmatic Research Project that will successfully generate R&D products (e.g., knowledge, tools, and methods) that will be in high demand and have tremendous potential to advance the scientific knowledge and technical capability of PN researchers across the country.